AADR Bloc Travel Grant for Dental Students and NIDCR Supported Trainees

Project Summary
The American Association for Dental Research (AADR) Bloc Travel Grant for Dental Students
and NIDCR-Supported Trainees aims to target a diverse pipeline of the dental, oral and
craniofacial research workforce by providing travel and meeting support to the most promising
U.S. dental students and NIDCR-funded trainees and fellows to attend and present their own
research at the AADR Annual Meeting – the leading national multi-disciplinary scientific meeting
for the oral, dental and craniofacial research field. The AADR is one of 28 Divisions of the IADR,
which was founded in 1920 and comprises more than 10,000 members worldwide. Enormous
and unacceptable oral health disparities exist across vulnerable and underserved populations
and we must have a well-trained, diverse oral health research workforce to accept these
challenges to improve dental, oral and craniofacial health. The objectives of this grant proposal
are: to provide financial travel support to assist new researchers to present their research on a
public scientific platform; to expose U.S. dental students and NIDCR supported trainees and
fellows to research conducted at institutions across the United States and globally, and to
enhance the opportunities for networking, collaboration and cross-institution mentorship; to
provide support to encourage a group of new investigators at a very early stage of their career
to further pursue dental, oral and craniofacial research as a long-term career; to provide a
means by which U.S. dental students and NIDCR supported trainees and fellows may obtain
information on the most current dental investigations and methodologies being conducted, and;
to proactively outreach and encourage applications from women, under-represented minorities
and persons with disabilities. The AADR is requesting support for this AADR Bloc Travel Grant
program for three years for travel assistance for students to attend the AADR Annual Meetings
scheduled in the following locales: Boston, Massachusetts (2021); Atlanta, Georgia (2022) and
Portland, Oregon (2023). As with each AADR Annual Meeting, meeting facilities are secured at
each location to allow for simultaneous oral sessions, poster sessions, symposia, hands-on
workshops, lunch and learn sessions, keynote lectures and distinguished lecture speakers. The
AADR Bloc Travel Grants will be administered through the IADR/AADR Global Headquarters.

Public health relevance
Project Narrative Enormous and unacceptable oral health disparities exist across vulnerable and underserved populations, cleft lip and palate remains a common birth defect, oral cancer is rising in young adults – likely related to HPV, and we’ve yet to harness the true diagnostic value of salivary biomarkers or leverage the tremendous genomic medicine advances for oral health improvement. Dental caries remains one of the most common diseases of childhood; periodontal disease prevalence estimates have recently been revised upwards to nearly half the adult populations after a more thorough full-mouth exam methodology; oral health consequences of the use of e-cigarettes remain largely unknown; temporomandibular joint disorders (TMJDs) are a diverse and still poorly understood set of complex and painful conditions; and our understanding of the oral microbiome in the maintenance of health and the pathogenesis of disease is rapidly unfolding. We must have a well-trained, diverse oral health research workforce to accept these challenges to improve dental, oral and craniofacial health. .